Primary Human Airway Cell Culture Core

PROJECT SUMMARY/ABSTRACT
Core D Cell Culture
The goal of the work described in this proposal is to collect grow, store and expand airway epithelial cells
and smooth muscle cells. These cells will come from bronchoscopic biopsies (brush biopsies for epithelial
cells and endobronchial biopsies for smooth muscle cells) from Core B. The main site for collecting, growing
and storing the cells will be at IU, but there will be a satellite facility at CWRU to grow cells from
bronchoscopies in Cleveland. Subjects will include both severe asthma patients and healthy control
subjects. Cells will be provided to investigators from both sites to each or the Projects for use in their Aims,
as described. Cells will be catalogued and labeled (by bar code) by study number from Core C. This will
allow analysis of the relationship between clinical phenotype, drug response, genotype (for Project 3) and
airway cell behavior. Cells will be stored long-term at the IU site. Each sample can be thawed and further
expanded for study and testing at the IU site. The ability to collect, expand, and distribute airway epithelial
cells to researchers will have a positive impact on understanding and developing therapies for common
airway diseases. This will be the only core with these capabilities at either site.